Regulation of Flt 1 Splicing by Fibronectin and Integrin Signaling During Aging

Abstract
Risk factors for cognitive impairment and dementia target the vasculature, a condition known as
Vascular contributions to Cognitive Impairment & Dementia (VCID). However, the molecular
mechanisms that result in reduced vascular function, density and perfusion in disease are
poorly understood. Recent work has focused on vascular endothelial growth factor (VEGF),
which signals through VEGF receptor 2, and is a major contributor to endothelial cell survival
and vessel maintenance. VEGF bioavailability declines with age, leading to vascular dysfunction
and reduced vessel density in the brain and other organs. This effect is due to increased levels
of a VEGF antagonist, an alternatively spliced soluble form of the decoy receptor VEGFR1,
termed soluble Flt1 (sFlt1), primarily expressed in the endothelium. Interestingly, the above risk
factors for vascular disease – age, diabetes, hypertension and vascular injury – are linked to
increased subendothelial accumulation of the extracellular matrix protein fibronectin (FN) in
vascular basement membrane. FN contributes to vessel repair and integrity but in disease
settings can drive inflammation and dysfunction. Preliminary data show that, under conditions of
high substrate stiffness, cell adhesion to FN through integrin α5β1 induces alternative splicing of
the Flt1 transcript to increase sFlt1 production These findings lead us to propose the novel
hypothesis that FN accumulation and vessel stiffening with age drives increased production of
sFlt1, which mediates vascular rarefaction in the brain and impairs cognitive function. In the first
Aim, we will determine how mechanical strain on integrin α5β1 leads to Flt1 splicing and
premature polyadenylation, identifying the RNA-binding proteins (RBPs) responsible for the
change in splicing and elucidating mechanisms of regulation. In the second Aim, we will test the
above hypothesis in mouse models and identify therapeutic targets whose blockade prevents
sFlt1 production and protects from cognitive impairment. Together, the completion of these aims
will provide new molecular insights into VCID by linking the increased vascular accumulation of
FN to the production of sFlt1, determining molecular mechanisms, and identifying ways to inhibit
this pathway to limit vascular rarefaction and cognitive decline associated with VCID risk factors.

Public health relevance
Narrative Vascular dysfunction and rarefaction is a major risk factor for cognitive impairment and dementia of all causation, including Alzheimer’s and Parkinson’s diseases as well as vascular dementia. Age, diabetes, hypertension, vessel stiffness and long-term consequences of COVID19 infection are risk factors, all of which increase deposition of subendothelial fibronectin (FN). Here, we investigate the hypothesis that increased FN in vascular basement membranes drives production of a soluble form of vascular endothelial growth factor receptor (sFlt1) that inhibits the VEGF signaling to cause the vascular dysfunction and rarefaction that drives cognitive decline. These studies include testing whether blocking FN-integrin signaling pathways in mouse models of aging and disease inhibits vascular rarefaction to improve cognitive function.